Administrative Core

PROJECT SUMMARY ADMIN CORE
The goal of the Administrative (Admin) Core is to provide management, oversight and logistical support for
the proposed Jackson Laboratory-Icahn School of Medicine at Mt. Sinai Collaborative Center on Human
Immunology (JAX-ISMMS CCHI). The essential functions of the Admin Core are to: 1) facilitate
communication and foster a strong collaborative environment among the Center Directors/Investigators; 2)
establish the External Scientific Advisory Group (ESAG), coordinate annual ESAG meetings and implement
their recommendations for improvement or advancement; 3) maintain alignment of the JAX-ISMMS CCHI
with the goals and objectives of the broader CCHI program; 4) monitor the progress of the research and
technology development Projects and Cores towards their specific research and resource development
goals; 5) optimize resource allocation and fiscal management; 6) ensure swift resolution of any logistic,
scientific and fiscal challenges; and 7) ensure efficient data sharing through ImmPort and policy
compliance. JAX and ISMMS are home to several NIH-funded research centers and have a long history of
successful contributions to NIH-funded consortium efforts. JAX and ISMMS also offer excellent capabilities,
facilities and resources to support the Admin Core and the CCHI as a whole. The Admin Core will be led by
Center Directors Drs. Karolina Palucka and Adolfo García-Sastre, both of whom have substantial
experience in center leadership, and will be supported by an experienced and dedicated Program Manager.
The Admin Core will promote the goals of the JAX-ISMMS CCHI and the broader program effort through the
following Specific Aims:
Aim 1. Optimize integration and function of JAX-ISMMS CCHI activities through strong administrative
and scientific oversight.
Aim 2. Enhance communication and collaboration among JAX-ISMMS CCHI investigators.
Aim 3. Exercise oversight of data management and dissemination to ensure efficiency and policy
compliance.
Aim 4. Manage resource allocation and fiscal accountability.